Integrated Health, Behavioral and Economic Research on Current and Emerging Tobacco Products

PROJECT SUMMARY/ABSTRACT
After decades of stability, the tobacco products people use and the way they use them are changing. Cigarette
use continues to decline, but e-cigarette, cigar, and moist snuff use are increasing and use of multiple products
is becoming more common. New “heat-not-burn” products are being proposed to the FDA as modified risk
tobacco products. There is only a limited evidence base to inform regulatory and public communication
responses to these changes. The integrative theme of this TCORS is that understanding combined health
effects, behavior, and impact analysis will provide actionable information for regulation of and public
communications about current and emerging tobacco products. This integration is reflected by the fact that
several projects fall within more than one domain. The TCORS' specific aims are: (1) Evaluate the short-term
health effects, including respiratory and cardiovascular effects, of e-cigarettes, heat-not-burn, and other
tobacco products and how specific tobacco product characteristics influence health effects and behavior; (2)
Develop the science base to inform product standards and marketing regulations for these tobacco products,
integrating the health and behavioral dimensions of tobacco use with economic models, with particular
emphasis on specific product characteristics and previously under-studied short-term effects; and (3)
Implement a career enhancement program for postdoctoral fellows, junior faculty, and established faculty who
are not currently involved in regulatory science research to build the tobacco regulatory science research
community through mentoring, developmental grants, and other support. We will accomplish these aims
through 5 projects: (1) Impact of Different E-cigarette Characteristics on Acute Lung Injury; (2) Short-term
Cardiovascular Effects of E-cigarettes: Influence of Device Power and E-liquid pH, and How E-cigarettes
Compare with Heat-not-burn Products; (3) Cardiovascular Health Effects of Emerging Heat-Not-Burn Tobacco
Products; (4) Current and Emerging Tobacco Products in a Rural Context: Influences of Product
Characteristics on Perceptions, Behaviors, and Biologic Exposures; and (5) Impact of Changing Tobacco
Product Use on Healthcare Costs for General and Vulnerable Populations. Four cores will support these
projects: (1) Administration; (2) Career Enhancement; (3) Statistics and Informatics; and (4) Biomarker All
projects and cores interact to support each other and increase their collective impact. The health effects
(Projects 1, 2, and 3) and behavior (Project 4) projects inform each other and are further integrated through
economic models (Project 5) that will improve regulatory impact analyses. Quantifying the health effects of
specific design aspects of tobacco products is important for identifying opportunities for regulation. In
particular, because benefits far in the future are heavily discounted in the FDA's regulatory impact analysis,
identifying short-term health effects is important for accurate regulatory impact assessment.

Public health relevance
PROJECT NARRATIVE Quantifying the health and behavioral effects of specific characteristics of tobacco products is important for identifying opportunities for regulation. In particular, because benefits far in the future are heavily discounted in the FDA's regulatory impact analysis, identifying short-term health effects is particularly important for accurate regulatory impact assessment.